Epigenetic entrainment of striatal engram-like neurons across the time course of LID development

Project Summary/Abstract
Levodopa (L-DOPA)-induced dyskinesia (LID) is a debilitating motor side effect of long-term use of
Parkinson disease (PD) medication. Proportionally higher output of the basal ganglia direct pathway compared
to the indirect pathway, resulting in hyperkinetic abnormal involuntary movements, is a circuit-level hallmark of
LID. Once developed, LID is difficult to mitigate and grows in severity with each successive dose. Our work
indicates that a subpopulation of D1 receptor-expressing medium spiny output neurons (D1-MSNs) are
transcriptionally altered by the development and stable expression of LID in animal models. This transcriptional
profile is reminiscent of that of hippocampal engram cells upon recall of an entrained stimulus. In addition,
manipulation of these specific D1-MSNs has been shown to bidirectionally mediate LID expression. THese
characteristics suggest that a specific subset of D1-MSNs may serve as engram cells for LID. However, the
evolution of cellular and molecular changes that uniquely occur in these engram-like D1-MSNs in response to L-
DOPA treatment across the time course of LID development have not been established to date. We have
previously observed that epigenetic processes play a key role in the development of LID, though these processes
have never been investigated in a cell type-specific manner. The critical next steps are identifying the unique
transcriptional, physical, and physiological characteristics of L-DOPA-responsive D1-MSNs upon both acute and
chronic L-DOPA exposure and determining the epigenetic mechanisms that may spur this process. The overall
goal of the work proposed in this application is to utilize genetic approaches to establish an engram-like
population of D1-MSNs utilizing a well-established preclinical model of LID in combination with a novel mouse
model, allowing us to specifically target the cells which underlie LID. We will utilize a transcription-to-behavior
approach to investigate cellular connectivity at the level of chromatin remodeling, transcription, cellular
morphology and physiology, and behavior. Our hypothesis is that LID development is associated with remodeling
of L-DOPA-responsive D1-MSNs (Aim 1), mediated by a shift in chromatin availability and corresponding
transcriptional networks (Aim 2), that underlies the transition from the acute to chronic LID state. To date, there
are no available therapies to halt LID development. The results from this research will indicate targets for LID-
mitigating therapies to prolong the usefulness of L-DOPA, the gold standard of PD therapy for over 50 years.

Public health relevance
Project Narrative L-DOPA-induced dyskinesia is a progressive, persistent motor side effect of long-term pharmacological treatment of Parkinson disease symptoms with the dopamine precursor, L-DOPA. Currently, there are no strategies to block its development and there are few mitigating strategies available. The goal of this project is to investigate whether specific neurons are responsible for the “memory” for L-DOPA drug history and whether epigenetic processes are involved in the recruitment of these specific neurons.